DEVELOPMENT OF A WEB-BASED INFORMATICS PLATFORM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The intent is to construct, from scratch, a centralized, web-based informational management and retrieval tool utilizing open-source industry standards for WWW development. This includes the ability for all groups of the YRC and collaborators to be able to access, change and analyze relevant data, with access control based on the YRC group and/or project membership.